Southwest Strategies to Innovate Emergency Care Clinical Trials Network (SW SIREN)

Medical and traumatic emergency conditions affecting the cardiac, respiratory, nervous, and hematologic systems collectively account for the overwhelming preponderance of death and disability affecting Americans. The ongoing COVID- 19 pandemic has brought into stark relief the importance of emergency care research to rapidly evaluate treatments, and the disproportionate burden that underserved populations suffer. It is imperative that new approaches for timely diagnosis and equitable treatment of these conditions be efficiently developed. This renewal application is to continue and evolve the effective Southwest Strategies to Innovate EmeRgENcy Care Clinical Trials Network (SW SIREN) Hub and Spoke system to conduct high-quality, multi-site clinical trials to improve the outcomes for patients with neurologic, cardiac, respiratory, and hematologic, and traumatic conditions. The SW SIREN consortium will leverage strong regionalized prehospital-medical center partnerships in major population centers in the Southwest (Los Angeles, Orange, and San Diego counties in California, Denver, Colorado, and Clark County, Nevada), with a continued focus on recruitment of underrepresented populations. The Hub-and-Spoke consortium is comprised of the Award Hub, 5 Core Spoke Medical Centers, 83 Additional Spoke Hospitals, and 5 County EMS systems. Within the consortium are a total of 10 tertiary-quaternary academic centers able to participate in complex intervention trials and an extensive range of frontline hospitals able to participate in simple pragmatic trials. Building upon our success in training and mentorship of fellows and mid-career clinical trialists, we will utilize six Clinical and Translational Science Awards and seven universities to identify and elevate the next generation of SIREN clinical trialists. Twelve Advisory Panels with expertise in specific disease and research domains will facilitate trial implementation within the consortium and serve as a resource to the Hub leadership and to individual performance sites. The four specific aims of this proposal are to: 1) perform high-quality pragmatic clinical trials in several different types of emergency disorders afflicting adults and children throughout the Southwest; 2) facilitate collaboration between emergency medicine physicians, disease specialists, and EMS systems throughout the Southwest in trial design and execution; 3) provide an educational environment that provides opportunities for designated SW SIREN junior faculty fellows to participate in clinical trial research under the supervision of experienced investigators and disseminates knowledge about emergency care to medical students, residents, fellows, and allied health professionals; and 4) ensure equitable participation of a substantial number of patients with emergency conditions in SIREN clinical trials, including women, children, Hispanic-Americans, African-Americans, and other traditionally underrepresented populations.

Public health relevance
Medical and traumatic emergency conditions affecting the cardiac, respiratory, nervous, and hematologic systems collectively account for the overwhelming preponderance of death and disability affecting Americans. The ongoing COVID-19 pandemic has brought into stark relief the importance of emergency care research to rapidly evaluate treatments, and the disproportionate burden that underserved populations suffer. It is imperative that new approaches for timely diagnosis and equitable treatment of these conditions be efficiently developed.